Administrative Core

The Administrative Core of the UT Southwestern O'Brien Kidney Center provides scientific and fiscal oversight of the Center. The Administrative Core supports the attainment of the Center's goals through a simple yet effective administrative structure that can readily adapt to the changing needs of investigators and the emergence of new technologies. The Administrative Core insures that the O'Brien Kidney Center efficiently interacts with core users as well as other core facilities, centers, and educational programs at UT Southwestern. Additionally, the Administrative Core oversees the Pilot and Feasibility Program and the Educational Enrichment Programs to insure that they are meeting the needs of the participants. The specific aims for the next funding cycle are: 1) Provide scientific oversight of the biomedical research cores, 2) Administer the Pilot and Feasibility Program, 3) Support the Educational Enrichment Program, 4) Provide fiscal oversight of the Center's operations, 5) Continue to expand the user base of the Center, and 6) Provide the infrastructure needed to operate the cores and facilitate the interactions with users. To achieve these goals, the UTSW O'Brien Kidney Center is led by an Executive Committee comprised of the Center Director, Associate Director, and the Directors of the P&F Program and Enrichment Program. The Executive Committee meets regularly with the Core Directors to oversee the services and appoint Center Investigators. An External Advisory Committee composed of seven experts in the fields of kidney development, renal physiology and pathophysiology, and CKD meets annually to review the Center and assist with the selection of the P&F projects.